Support to the DOE for the Instrumentation for Advanced Beam Lines

This agreeement is between the National Center for Research Resouces (NCRR), NIH, and the Department of Energy (DOE) to provide support for instrumentation for advanced beam lines that will support research needs of the life sciences community at the National Synchotron Light Source-II (NSLS-II) at Brookhaven National Laboratory (BNL).